Revealing the complexity of dis-inhibitory circuitries

PROJECT SUMMARY
Salient signals, like aversive stimulation and reward, should be faithfully detected, and processed by the
nervous system to generate an adaptive action. One of the universal circuit mechanisms linked to salient signal
processing in cortical operation is the activation of dis-inhibitory neurons by subcortical afferents. Aversive
signals and reward delivery profoundly excite cortical GABAergic interneurons expressing vasoactive intestinal
polypeptide (VIP), which selectively inhibit other GABAergic interneurons, leading to the dis-inhibition of
cortical pyramidal cells. In this project, we propose to reveal the functional diversity of VIP interneurons in a
cortical structure. The central idea of our project rests on our earlier anatomical findings that distinct groups of
VIP interneurons innervate different types of GABAergic interneurons, observations that prompted us to
suggest a heterogeneity in their activity during various cortical processes. However, recent imaging studies
reported rather similar activity of VIP interneurons following aversive and appetitive stimuli. In contrast to these
in vivo imaging data, our preliminary experiments obtained in a frontal cortical area of anesthetized mice have
revealed a considerable heterogeneity in VIP interneuron spiking upon delivery of foot shocks. Building on
these preliminary results, our goal is to determine the functional complexity of cortical VIP interneurons,
including their connectivity and operation in awake mice. To achieve these aims, we will combine viral
techniques, neuroanatomical methods, in vivo and in vitro electrophysiology with optogenetics in three different
genetically modified mouse lines. The results of this project will uncover the heterogeneity of spike responses
generated by genetically defined dis-inhibitory VIP interneurons upon salient signal delivery and their
downstream effects on postsynaptic partners within the local microcircuits. Our project will reveal the
complexity of dis-inhibitory circuit motifs in cortical networks, which may be a general phenomenon in a cortex-
wide manner. In addition, our results will help form novel concepts underlying the pathological operation of
cortical circuits linked to deficits in attention and salient signal detection that typifies many malfunctional
cognitive processes, including those observed in schizophrenia, autism, and attention deficit.

Public health relevance
PROJECT NARRATIVE One of the first steps in salient signal detection in cortical structures is the profound activation of dis-inhibitory interneurons expressing vasoactive intestinal polypeptide (VIP). In contrast to the current view, we propose that VIP interneurons can be divided into functionally distinct groups. By combining viral techniques, neuroanatomical methods, in vitro and in vivo electrophysiology, we will determine how distinct, genetically defined types of VIP interneurons respond to aversive signal presentation and reward delivery as well as reveal their target selectivity, the critical parameters underlying circuit mechanisms of salient signal processing in cortical structures.